FSMA Produce Education, Outreach and Enforcement for the state of MT

Montana Produce Plan A&B Summary (Per Part A) Montana Department of Agriculture (MDA) will create produce implementation working group and provide training to producers. MDA will implement the FSMA laws into state law. MDA will assure staff is properly trained and then provide education opportunities to allow for full FSMA produce compliance by all growers. (Per Part B)MDA will make sure that all inspection staff are ready and able to perform FSMA produce inspections by year two and will conduct all needed inspections from project years 2-5.

Public health relevance
PROJECT NARRATVE Montana Department of Agriculture's Produce Project has three fundamental goals in part A and two in part B. Part A 1.1)To create maximum opportunities for Montana produce growers, educators, and regulators to get all of the training necessary to understand and comply with the produce rules of FSMA. 1.2)To provide a framework for regulatory agents to communicate and modify the Montana produce regulatory environment so that all growers are known, trained, and operating in a manner to enhance safety and tractability of Montana Produce. 1.3)To decrease fear and anxiety growers may have as to the complexity or cost of compliance and to reassure all growers that FSMA compliance is not a barrier to entry into growing covered crops. Part B 1.1.1.1) To inspect all covered produce producers every year 1.1.1.2) To aim for a compliance-based enforcement environment that proactively addresses concerns as they arise.